Organization of Excitatory and Inhibitory Circuits in ASD

DESCRIPTION (provided by applicant): Converging evidence from diverse experiments suggests that the balance of excitation and inhibition is disrupted in autism with widespread repercussions on neural communication. The goal of the proposed project is to investigate the largely unexplored issue of the integrity of neural elements that underlie excitatory and inhibitor control within prefrontal networks. Experiments will be conducted on post-mortem brain tissue from 3- 10 year old children, using the robustly interconnected anterior cingulate, orbitofrontal, and lateral prefrontal cortices as a model system. These areas have a key role in the processes of attention, emotions and behavioral flexibility, which are consistently affected in autism. The overarching hypothesis is that altered brain connectivity in autism affects in distinct ways short and long-range frontal cortical pathways and local inhibitory neurons, disrupting neural communication and the balance of excitation and inhibition. This hypothesis will be tested by investigating the status of: (1a) excitatory axons in the deep white matter that link prefrontal cortices with distant areas, which are desynchronized in autism; (1b) excitatory axons and their expression of the growth-associated protein GAP-43 in the superficial white matter, which links neighboring prefrontal areas and is enlarged in children with autism; (2) excitatory axons and their expression of GAP-43 in different cortical layers that receive or issue driving feedforward o modulatory feedback pathways in prefrontal cortices in autism, and; (3) the laminar composition and relationships of three functionally distinct neurochemical classes of inhibitory neurons in prefrontal grey matter, which underlie cortical inhibitory control. Data will be used to: (4) computationally model complex interactions of frontal circuits, associated with the integration of attentional and emotional processes, and the ability to flexibly shift attention, which are commonly disrupted across the autism spectrum. The choice of ages 3-10 years aims to capture documented atypical and typical development of the prefrontal cortex of children with autism and controls. Axons will be double-labeled for myelin, and for GAP-43, which is expressed in development and after brain injury, for study at the light, confocal, and electron microscopes, and will be reconstructed in 3D. Inhibitory neurons will be labeled to distinguish functional classes by their neurochemistry and known mode of innervation. Findings will provide a rich quantitative database on the features of excitatory axons and inhibitory neurons in the brains of children with autism to compare with age-matched controls and with available data of persistent changes in axons in the prefrontal white matter of adults with autism. Comparison across ages will help delineate a timeline for the developmental changes in autism, and help design future experiments to study whether early axon growth or persistent inflammation may underlie the pathology. The proposed studies will provide novel data on fine features of neural elements to model the disrupted excitation-inhibition and neural communication in autism. The findings will have important implications for the development of therapeutic interventions in autism.

Public health relevance
PUBLIC HEALTH RELEVANCE: Atypical connectivity in the brains of individuals with autism desynchronizes brain activity by altering the delicate balance of excitation and inhibition, especially in frontal cortical circuits, which exhibit overall disorganization and excessive local connectivity between nearby areas. Damage to these networks in autism affects social interactions and communication, and may help explain why individuals with autism do not adequately shift attention, and engage in repetitive and inflexible behaviors. Investigation of the features of neuronal axons, which comprise these pathways, and their synaptic interactions with excitatory and inhibitory systems in children and adults with autism will identify fundamental mechanisms underlying disrupted communication, and help delineate a timeline for the onset and development of neuropathological changes, with important implications for the design of novel therapeutic interventions in autism.